2024 Pediatric Dermatology Research Alliance (PeDRA) Annual Conference

PROJECT SUMMARY
Pediatric skin diseases are highly prevalent and impart a devastating burden on children and their families.
Yet, the specialty of pediatric dermatology is understaffed, the availability of FDA-approved treatments is
inadequate, and the pace of research and guidelines development in the field is too slow. The Pediatric
Dermatology Research Alliance (PeDRA) was founded in 2012 to address these crucial yet unmet needs.
PeDRA’s primary mission is to create, inspire, and sustain research to prevent, treat, and cure childhood skin
disease. The long-term goal of PeDRA is to leverage such research to improve the health outcomes of children
with skin disorders. Annual conferences have been integral to the success of PeDRA, providing a forum for
educating investigators, identifying and prioritizing research needs and opportunities, and developing and
initiating innovative projects. A combination of didactic lectures and panels, expert-led small group discussions,
poster sessions, and unique training opportunities are the foundation of every PeDRA Annual Conference. This
proposal is for the 12th PeDRA Annual Conference, set to take place in October of 2024 with the following
aims: 1) Provide education and engagement opportunities for a broad and diverse audience with a focus on
establishing a core set of competencies and resources to conduct successful pediatric dermatology research;
2) Advance existing research projects and develop new research priorities and initiatives in disease-areas and
high-priority topics spanning the field of pediatric dermatology; and 3) Provide a forum for the dissemination of
final and ongoing research results from a broad group of investigators to a diverse audience that includes
patient stakeholders, industry representatives, and researchers from multiple fields including potential NIH
collaborators. The expected outcomes of this conference are a more developed set of research skills for
current and future physician-scientists, enhanced productivity, strengthened multi-stakeholder networks, and
the conduct of high-quality research. These activities will accelerate the pace of pediatric dermatology
research, allowing clinicians to better understand, prevent and treat skin disease in children, and giving
patients and families options to manage diseases and make informed treatment decisions in the future.

Public health relevance
PROJECT NARRATIVE Established in 2012, the Pediatric Dermatology Research Alliance (PeDRA) is a nonprofit research organization driven by the mission to create, inspire, and sustain research to prevent, treat, and cure childhood skin disease, and the PeDRA Annual Conference has been integral to the organization’s growth and success since the first conference in 2013. In 2024, its twelfth annual conference will continue PeDRA’s work to educate and empower physician-scientists, trainees, and other stakeholders through an agenda that disseminates results, supports the identification of high-priority questions, and facilitates science with a focus on innovative solutions to advance pediatric dermatology research. The conference will accelerate the pace of pediatric dermatology research in pursuit of PeDRA’s vision of changing lives and healing children with skin disease through collaboration and discovery.